The PET Radiotracer Translation and Resource Center (PET-RTRC)

Overall Project Summary
In this renewal application of our National Center for Biomedical Imaging and Bioengineering (NCBIB), the PET
Radiotracer and Translation Center (PET-RTRC), our objective is to further fortify the Center as a national
resource that leverages the expertise at Washington University and the Mallinckrodt Institute of Radiology in
PET radiotracer design, development, production, training and dissemination. In collaboration with research
groups throughout the country and in Europe who are studying molecular and cellular processes of inflammation
in disease, we will further enhance the development and dissemination of novel PET radiotracers needed to
transform biomedical research and advance human health. In the process we will strengthen the foundation for
propelling the PET-RTRC forward and sustaining its long term operation. To fulfill our objective we will address
the following Specific Aims:
Aim 1: In responding to the scientific needs of the Collaborative Projects (CPs), the three Technological
Research & Development Projects (TR&Ds 1-3) will build upon their successful innovations during the current
funding cycle to develop radiotracers that target different components of inflammation, their dynamic variation,
and consequences such as inflammasome activation (TR&D 1: sphingosine-1-phosphate receptor-2),
monocyte/macrophage trafficking (TR&D 2: chemokine C receptor 2/CD163) and the induction of mitochondrial
stress (TR&D 3: mitochondrial reactive oxygen species). Aim 2: Given the importance of the CPs as technology
drivers, we will further enhance the “push-pull” interaction between the individual TR&Ds and their respective
CPs by including strategies that enhance cross-site communication, more robust training opportunities,
optimized image analysis and data management and facilitated sharing of intellectual property. Aim 3: The
Technology Training and Dissemination Core expands its success in the current grant cycle to offer robust
training and dissemination opportunities. In the training component, all Center workshops and seminars will be
presented in a hybrid onsite/remote mode, individualized training will be offered via proctored “how to” videos
on key topics and additional outreach initiatives will be implemented that are geared towards interactions with
other P41 Centers, internal WU training grants/programs and traditionally underserved universities. New
innovations in our dissemination efforts will increase the capabilities of our Service Projects for both pre-clinical
and human studies. The Administration Core will continue to provide the managerial oversight necessary for
the efficient operation of the PET-RTRC so that it meets its scientific, training and dissemination objectives.
Successful completion of the proposed renewal application will further propel the PET-RTRC as a national
resource to facilitate research that will increase our understanding of the molecular basis of disease, thus
providing the framework for novel diagnostic and therapeutic paradigms leading to improved human health.

Public health relevance
Overall Project Narrative PET Radiotracer and Translation Center (PET-RTRC) is a national resource that leverages the expertise of research groups throughout the country and in Europe to enhance the development and dissemination of novel PET radiotracers needed to transform biomedical research and advance human health.